Muller glia: roles in retinal homeostasis and neuronal regeneration

? DESCRIPTION (provided by applicant): There is a rapidly growing body of evidence that Müller glia can are a source of retinal progenitors to promote neural regeneration. Many studies have demonstrated that Müller glia can become proliferating progenitor cells in the retinas of different vertebrate species. Most reports have studied Müller glia-derived progenitors in acutely damaged retinas. However, little is known about the mechanisms that stimulate neurogenesis from Müller glia-derived progenitors in undamaged retinas or retinas undergoing slow, progressive degeneration. Furthermore, the regeneration of retinal neurons in warm-blooded vertebrates is limited compared to that seen in cold-blooded vertebrates. Therefore, the identification of the secreted factors and signaling pathways that permit and/or stimulate neural regeneration from Müller glia-derived progenitors is crucially important to developing new therapies to treat degenerative diseases of the human retina. We have obtained compelling novel preliminary data indicating that signaling through the glucocorticoid receptor (GCR) and the mTor-pathway significantly impacts the plasticity of Müller glia and neurogenic potential of Müller glia-derived progenitors. We will investigate how the phenotype and plasticity of the Müller glia are regulated by GCR- and mTor-signaling in normal, damaged and growth factor-treated retinas. We will use a combination of pharmacological and genetic approaches to selectively activate or inhibit GCR- or mTor-pathways in Müller glia. We will compare and contrast how GCR- and mTor-pathways impact the formation of Müller glia-derived progenitors in chick and rodent model systems with different inherent capacities for retinal regeneration. We expect that the completion of the experiments described in this proposal will provide significant new information regarding how GCR and mTor-signaling influences the formation of Müller glia-derived progenitors and regeneration of retinal neurons. Identification and understanding of the mechanisms that enhance the neurogenic potential of Müller glia is required to develop new therapies for sight-threatening diseases, such as glaucoma and macular degeneration that involve the loss of retinal neurons.

Public health relevance
PUBLIC HEALTH RELEVANCE: A thorough understanding of the mechanisms that regulate the functions of glial cells is crucially important to the development of new therapies to treat sight-threatening diseases of the retina. A primary function of retinal glia is to support neuronal function and survival. In addition, retinal Müller glia is known to have the potential to become neurogenic progenitor cells. Identification and understanding the mechanisms that regulate the neuron-supporting actions and neurogenic potential of Müller glia-derived progenitors is key to developing new therapies to treat degenerative disease of the retina. This proposal seeks to identify important signaling pathways that enhance the ability of Müller glia to become proliferating progenitors and produce new functional neurons. A goal of this project is to study the molecular mechanisms and signaling pathways that regulate glial functions related to reactivity, proliferation, and neuronal regeneration. Another goal of this project is to investigat how to enhance the ability of retinal glia to support the survival or retinal neurons by regulating cell signaling pathways. The findings produced by the proposed studies will provide valuable new insights into the factors and signaling mechanisms that regulate inter-glial communication, glia-mediated neuronal regeneration, and survival-supporting actions of retinal glia.